Development and Validation of Efficacy Biomarkers for QTE Therapy in Friedreich's Ataxia

ABSTRACT
Friedreich's ataxia (FRDA), the most common inherited ataxia, leads to severe neurodegeneration, cardiac
dysfunction, and often results in death by age 35. Despite the availability of omaveloxolone, the first FDA-
approved treatment, its effectiveness is limited, and it is associated with several side effects. AnekaBio, in
partnership with the University of Florida, is developing an innovative multi-targeted therapy called QTE therapy
that addresses the complex molecular mechanisms underlying FRDA. Our preclinical studies demonstrate that
QTE therapy significantly outperforms omaveloxolone, enhancing critical FRDA target proteins, improving
cardiac function, reducing iron overload, and dramatically increasing survival rates in FRDAkd mice. A
therapeutic alternative that is effective, safe, and which can outperform the existing treatment could significantly
shift the treatment paradigm. The proposed Phase I STTR project focuses on identifying and validating efficacy
biomarkers—specific biological indicators in blood and muscle—that reliably measure the effectiveness of QTE
therapy. Utilizing advanced proteomic and transcriptomic technologies, we will conduct in-depth analyses in
FRDAkd mouse model to discover biomarkers that can be used to monitor QTE's therapeutic impact. These
biomarkers are essential for future clinical trials, as they will provide a reliable means of assessing treatment
efficacy and safety in humans. During the Phase II STTR, we will validate these biomarkers across different
species, including primates, and initiate human testing in collaboration with industry partners. This phase will
also focus on refining QTE therapy for clinical application, guiding us toward IND submission and the initiation
of clinical trials. Our ultimate goal is to transition QTE therapy from preclinical studies to clinical trials, establishing
it as a safer and more effective treatment option for FRDA. Through the identification of robust efficacy
biomarkers and collaboration with experts in drug development, we aim to transform the treatment landscape for
FRDA, offering new hope to patients affected by this devastating disorder.

Public health relevance
PROJECT NARRATIVE Friedreich's ataxia (FRDA), the most common inherited ataxia, causes severe neurodegeneration and heart issues, often leading to premature death by age 35. The limited efficacy and notable side effects of existing treatments highlight the urgent need for safer, more effective FRDA therapies. AnekaBio, LLC introduces an advanced QTE therapy which, according to preclinical studies, surpasses the performance of existing treatments for FRDA, indicating a potential paradigm shift in managing this debilitating condition.